Understanding the role of IDH in malignant gliomas

ABSTRACT

Gliomas remain among the most intractable problems in oncology. These tumors can be differentiated into 2 distinct
subsets based on genetic profile. Those harboring mutations in Isocitrate Dehydrogenase 1 or 2 (IDH1/2) tend to occur
in younger patients and follow a progression from slow growing, indolent tumors (low-­‐grade), to rapidly proliferating
high-­‐grade tumors. The IDH gain-­‐of-­‐function mutations catalyze the reduction of α-­‐ketoglutarate (αKG) to 2-­‐
hydroxyglutarate (2HG), an oncometabolite that accumulates in millimolar concentrations in the tumor cell. 2HG has
been shown to drive the malignant phenotype in a wide variety of cancers that harbor IDH1/2 mutations. The presence
of these mutations in the earliest grade of glioma suggests that dependence on IDH may be during the indolent phase,
prior to transformation to higher grade, which is characterized by an accrual of multiple tumor suppressor and
oncogenic mutations that are powerful drivers of tumor proliferation. Adding support to this idea, we have
demonstrated that despite low proliferative rates, the low-­‐grade gliomas are highly metabolically active. We used 13C-­‐
NMR in vivo in patients with IDH-­‐mutated gliomas to determine the activity of metabolic pathways in low-­‐ and high-­‐
grade disease. Across the spectrum, we observed robust labeling of citric acid cycle intermediates and the 2HG pool
from both substrates, a finding that is particularly striking for the low-­‐grade gliomas and suggests that the metabolic
state is independent of the proliferative state. Emerging phase 1 glioma clinical trial data from treatment with the
selective IDH1 inhibitor, AG-­‐120 (Agios Pharmaceuticals), shows that treatment of progressive low-­‐grade gliomas, before
radiographic progression to high-­‐grade disease, is associated with prolonged stable disease. This is in marked contrast
with rapid progression in patients with recurrent high-­‐grade gliomas treated with the inhibitor. The question remains as
to what the mechanism of stable disease is in the low-­‐grade subgroup and whether treatment at an even earlier stage
(prior to progression in the stable phase) is the optimal time for achieving a response. We hypothesize that low-­‐grade
gliomas, during the long period of stable disease prior to further transformation, are highly metabolically active with
multiple substrates contributing to the dynamic regulation of the 2HG pool and in this state are dependent on sustained
production of 2HG. Furthermore, we hypothesize that following progression to high-­‐grade disease sustained production
of 2HG is no longer essential to tumor growth. To test these hypotheses, we have 3 Specific Aims: 1) To investigate the
cellular, molecular, and metabolic consequences of IDH1 inhibition in patients with low grade glioma with the goal of
determining whether IDH is a driver mutation in the setting of very low tumor cell proliferation; 2) To determine
whether high grade glioma progression on an IDH inhibitor is due to intrinsic or acquired resistance and assess the
impact of IDH inhibition in the setting of radiation and/or chemotherapy using clinically validated IDH mutant patient
derived xenograft mouse models; and 3) To dynamically image metabolic processes in vivo and develop biomarkers of
IDH response/lack of response. The impact of these studies will be directly translatable to clinical trials and clinical
management of IDH-­‐mutant gliomas for which improved therapeutics are desperately needed.

Public health relevance
Narrative Early stage breast cancer encompasses a broad range of histological subtypes with profoundly different clinical outcomes. We propose a translational research study that uses 13C- ‐NMR to identify the bioenergetic substrates and metabolic pathways that are utilized by early stage breast cancers and determine whether there are changes that occur in chemo- ‐resistant tumors and those that have already metastasized at diagnosis. The overarching goal is to understand where the metabolic vulnerabilities lie as a basis for identifying potential new therapeutic targets.